IVIG TREATMENT OF CHILDREN WITH SYMPTOMATIC HIV INFECTION

Intravenous gammaglobulin was being evaluated for beneficial effect in the prevention of secondary infections in infants and children with HIV infection and AIDS.